ShEEP Request for a Multimodal Plate Reader

The requested instrument is a Molecular Dynamics Spectramax id5 multi-mode Microplate reader
with dual injectors. It is used to perform assays based on spectrophotometry, fluorimetry, time-
resolved fluorescence and luminescence. This type of instrument is widely used in biomedical
research for measuring amounts of certain chemicals such as ATP and of biological substances such
as hormones, antibodies and growth factors. It can also be used to test for specific types of protein-
protein interactions. It will replace existing though aging equipment that is reaching the end of its
service life. It will also be adding capabilities our current instrumentation lacks, such as dual injectors
for use in flash assays such as measurement of ATP levels, and the capacity to make measurements
using 384-well plates. Its availability will enhance ongoing VA-funded projects focused on reducing
bone loss due to spinal cord injury, advancing understanding of the diagnosis and treatment of
dementia, greater understanding of Gulf War syndrome and other disorders related to miliary service,
traumatic brain injury, renal disease and blood pressure control. By doing so, the equipment will
accelerate the pace of VA research aimed at improving health and quality of life of Veterans.

Public health relevance
The application proposes the purchase of a state-of-the-art device to make laboratory measurements based on either absorbance of light at specific wavelengths, fluorescence of detector molecules or light emitted during biochemical reactions. The device is used in a wide range of VA research from cancer biology to studies of renal disease, dementia, service-related conditions such as Gulf War Syndrome and spinal cord injury. Having the ability to perform these measurements through a readily available and high-quality shared instrument will assure the most rapid and efficient progress of VA research design to improve the health and quality of life of Veterans.